BASE AWARD FOR USING RODENT BEHAVIORAL MODELS TO IDENTIFY SUBSTANCE ABUSE PHARMACOTHERAPIES

Rodent Behavioral Models to Identify Substance Use Disorder Pharmacotherapies

The National Institute on Drug Abuse (NIDA) is the largest supporter of the world’s research on substance use and addiction. Part of the National Institutes of Health, NIDA conducts and supports biomedical research to advance the science on substance use and addiction and improve individual and public health. Look below for more information on drug use, health, and NIDA’s research efforts.

Our mission is to advance science on drug use and addiction and to apply that knowledge to improve individual and public health.